Broad Institute LINCS Center for Transcriptomics

DESCRIPTION (provided by applicant): The overall goal of this LINCS Center is to make it to generate large-scale pharmacological and genetic perturbations of a large panel of cell types, develop analytical tools that enable researchers to make biological discoveries from the data, and to make those data and tools broadly available to the research community. We will accomplish this using the L1000 transcriptional profiling method developed by our Center, and by creating a cloud-based computing infrastructure that supports data APIs and web apps designed make it possible for biologists lacking computational expertise to make LINCS-based discoveries.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project is expected to have significant impact on a broad range of the biomedical research community. It has the potential to yield new approaches to genome functional annotation, to provide a path toward the elucidation of mechanism-of-action of small-molecule compounds, and to facilitate the discovery of drugs with unanticipated therapeutic effects on disease biology. By including a significant outreach and training component it will make researchers from across many biomedical institutions conversant with the applying the resources generated to these important problems in health science.